Small Molecule Drug Development

SMALL MOLECULE DRUG DEVELOPMENT (SMDD) SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Small Molecule Drug Development (SMDD) SR's mission is to assist researchers in creating high-quality
chemical probes to test therapeutic concepts. Utilizing High-Throughput Screening (HTS) and High Content
Analyses (HCA), it identifies active small molecules, aiding in the refinement of these “hits” into defined probes.
The SMDD SR offers resources for drug repurposing and new small molecule discovery.
From 2018-2023, the SR collaborated with 71 investigators, 58% being Case CCC members, completing 74
high-throughput screen projects and numerous custom assays. It has aided over 100 grant applications, securing
over $11 million in funding. The SR has supported 100+ users from Case Western Reserve University (CWRU),
University Hospitals, Cleveland Clinic, and other institutions, receiving highly positive feedback.
The Specific Aims of the Small Molecule Drug Development Shared Resource are to:
1. Provide assay development and high-throughput screening services, using innovative approaches to
screen bioactive compounds and diverse screening libraries.
2. Share expertise to design and optimize robust high-throughput assays tailored to specific projects.
3. Train new users, including PIs, research scientists, and trainees, in the proper and safe operation of the
SR's automation equipment and manage their participation during assay development and execution.
4. Offer advice and guidance to advance hits to leads using cheminformatics and medicinal chemistry.
5. Guide users toward SRs and potential collaborating investigators in Case CCC research programs with
complementary capabilities relevant to drug development.
The SMDD SR's development has led to its integration with the CWRU School of Medicine (SOM) Chemical
Biology Program. The SR has enhanced its microscopy capabilities with the Agilent Cytation5 HTS imager and
broadened its small-molecule libraries with NCI Natural Products and AC-Discovery's MEGx library.
The SMDD is broadening its user base and services, aiming to add 5-10 new users yearly for assay development
and maintain a robust assay pipeline for future large-scale screens, expecting 3-5 funded high-throughput
screens annually. In 2024, the SMDD moved to a larger facility adjacent to the CWRU SOM Chemical Biology
Program and incorporated the Echo650 for advanced compound dispensing. The discovery library suits smaller-
scale assays, while the plan is to expand the Bioactives collection from 3,000 to 9,000-12,000 molecules to meet
higher throughput needs.